Center for Career Development in Women's Health

[unreadable] DESCRIPTION (provided by applicant): This competing renewal application for a Women's Reproductive Health Research (WRHR) Career Development Center seeks continued support for training and mentorship for obstetrician-gynecologists with the goal of cultivating a cadre of independent scholars in women's health, emphasizing multidisciplinary approaches. The program will have a steady state of 3 WRHR Scholars. The WRHR Center builds on a tradition of multi-faceted investigation and training in reproductive and women's health at the University of Pennsylvania dating back to 1966. It is an integral part of Penn's exceptional biomedical research enterprise, ranking second in the nation in terms of N.I.H. grant awards to medical schools. The short term goals of the [unreadable] WRHR Center are to identify especially talented physicians who have demonstrated potential for successful careers in research, to place them in an exciting and supportive research environment under the guidance of an experienced mentor(s), and to advance their skill sets in research to the point that they can establish a productive, independent line of investigation. Based on successes in the previous funding period, the WRHR Center will continue to formulate individualized curricula and career development plans. This may include enrollment in a Masters or Ph.D. degree program. Academic enrichment including seminars and specialized workshops has been established to enhance research skills as well as publication and grant writing. Continued support for a Biostatistics Core is requested based on its significant contributions to the research career development of Scholars during the past period of support. The long term goals of the Center are to insure that Scholars who graduate from the WRHR Center establish sustainable research programs, and develop expertise in mentorship that will allow them to guide future Scholars. The success of the Center will be measured in terms of the quality and importance of work published by the Scholars, their ability to win and retain extramural research funding, professional recognition for their research activities, effectiveness in mentoring trainees under their direction, academic promotion within the University of Pennsylvania or elsewhere, and assumption of leadership roles in the specialty of Obstetrics and Gynecology. [unreadable] [unreadable] [unreadable]